LEARN Science: A K-2 Life Science and Reading Program in Public Libraries to Improve Science Achievement through Storytelling

Project Summary/Abstract
Economically disadvantaged, racially-diverse youth lag their peers for science achievement by third grade.
Historic divestment in their communities may have already paved their path to poor adult health, fewer
employment opportunities, and lower economic mobility. LEARN Science – Library Efforts to Advance Reading
and Nutrition Science – blazes a new trail for youth using informal science education (ISE) through community
public libraries across Mississippi (MS). LEARN Science is a life science and reading program through a
nutrition science lens to improve science achievement among children in kindergarten through 2nd grade (K-2).
MS is characterized by educational and health disparities, yet it boasts a robust public library system. Public
libraries are potential: 1) bridges to improve Science, Technology, Engineering, and Mathematics (STEM)
inequities; and 2) key collaborators for health education and promotion. The role of food for survival is a
foundational scientific concept for children to learn in K-2. Food exposes youth to potentially dozens of
scientific concepts daily, as well as to cultural traditions and health principles. As such, nutrition education can
empower youth to make food choices for chronic disease prevention. Our overall long-term goal is to establish
LEARN Science to improve science achievement among children in K-2. The program will be aligned with Next
Generation Science Standards (NGSS) and be consistent with the social ecological model. LEARN Science
will consist of seven lesson units. Each unit will follow a storyline and blend two culturally- and age-appropriate
books with: 1) nutrition science terminology; 2) inquiry-based, hands-on activities using science tools; 4)
scientific observations and reflection; and 4) take-home family learning resources. Unit readings will include
both: 1) a narrative (fiction) book with a nutrition component; and 2) an informational (nonfiction) book
showcasing a scientist and/or a scientific principle. Units will include a mentor guide and information on
connecting families with community food resources. We will: 1) develop and evaluate the LEARN Science
program, utilizing latest educational best practices; 2) establish the NIH SEPA Library Academy, a professional
development program (PDP) focused on mentoring and building self-efficacy among library staff to deliver
LEARN Science across MS; and 3) disseminate LEARN Science across the MS public libraries. LEARN
Science will strengthen ISE opportunities for children in K-2, improve science achievement of children, and
ultimately has the potential to expand the number of children choosing STEM careers.

Public health relevance
Narrative Poor science achievement in childhood negatively impacts adult health, due to poor scientific literacy and reasoning. LEARN Science – Library Efforts to Advance Reading and Nutrition Science – is an informal life science and reading program through a nutrition science lens to improve science knowledge and science identity among children in kindergarten through second grade (K-2) in Mississippi using public libraries. Informal science education through a nutrition science lens leverages an opportunity for not only improved science achievement, but also for improved health of children – now and in the future.